Office of the Clinical Director

The Office of the Clinical Director (OCD), Intramural Research Program (IRP), National Institute on Drug Abuse (NIDA), NIH provides research support to two clinical research branches at the IRP. The scope of the research program is broad and is strongly represented in neuroimaging, while also incorporating both behavioral and pharmacological treatments for substance abuse disorders. The Office of the Clinical Director has a staff of two Administrative Assistants who provides primary support to the Director, Deputy Director, and Medical Officer. These Administrative Assistants also coordinate with the IRP Pharmacy, Matthews Media Group, Inc. (MMG), Medical Records Department, the Mid-Level Providers and Nursing. The four fulltime Mid-Level Providers (Federal) medically screen potential participants as well as assist in the day to day running of various protocols. Additional Clinical staff supporting the NDA/IRP programs include 5 full time RNs, 5 full time Research Associates, 1 part time Unit Secretary and 1 full time Patient Care Manager. These positions are part of the clinical services provided through the Johns Hopkins Bayview Medical Contract with NIDA/IRP. This contract also provides essential infrastructure and services including professional physician consultations, laboratory medicine and staff support. There are collaborative relationships with Behavioral Pharmacological Research Unit (BPRU) located on the Bayview campus and the Maryland Psychiatric Research Center (MRPC) located on the campus of Spring Grove State Hospital. The changes that have come about as a result of the move to the BRC have brought into focus the need to expand the numbers of nursing staff. The NIDA IRB office is under the direction of the OCD and is staffed by an IRB Administrator (Federal) and a Protocol Specialist (Contract). The office handles approximately 500 IRB related actions a year, from 65 active protocols. This year the IRB office has joined the NIH CNS IRB, and is in the process of merging with their electronic Protocol Tracking and Management System (PTMS), as well as integrating with NIHs Office of Protocol Services (OPS). The OCD oversees a fully funded contract with MMG, an outside organization. MMG represents NIDA/IRP, recruiting research participants in the Baltimore Washington area. At this time MMG employs 13 screening specialists, 2 patient counselors and a 3 member management team. There is a yearly budget of $225,000 for print, web, radio and television advertising and $50,000 for community outreach. The Medical Records Department at NIDA/IRP is designed to maintain department compliance of Policy and Procedures while safekeeping the Privacy of over 6300 electronic (HuRIS System) medical records annually. Both microfilm and/or DVD as well as hardcopy versions of the medical records are accessed for both in-house and outside sources. This is done according to the National Institute of Health, Federal and State Rules and Regulations (Including the Privacy Act of 1974 and HIPPA). The IRP Pharmacy employs two fulltime pharmacists. Along with the main pharmacy at the IRP, they manage a satellite location at MPRC on the Spring Grove Hospital Campus. This is part of the collaborative research agreement. The IRP pharmacy currently supports about 20 clinical studies including 5 Archway studies and 70 researchers/labs for nonclinical studies. One pharmacist devotes about 80% of her time supporting the Archway studies, including IND support. The other pharmacist spends about 60 % effort on clinical and 40 % effort on nonclinical studies. Clinical research support includes reviewing, preparing, compounding, and dispensing the study medications. Nonclinical support includes ordering, compounding, dispensing, and laboratory auditing. In addition, the pharmacy monitors drug inventories, and meets all DEA and FDA regulatory requirements including licensing and IND reporting.